Website communication services for NCI, DCCPS

DCCPS supports web-based, online, electronic and other communication and education efforts as part of its mission. These activities enable the organization to be more interactive with stakeholders by sharing important information about research portfolios and the resulting tools, products and scientific advances.